Cannabis Use and Proximal Immune Dysregulation (CUPID)

PROJECT SUMMARY/ABSTRACT
Background. Black sexual minority men (SMM) experience profound HIV-related disparities compared to non-
Hispanic White men, acquiring age-related diseases with greater symptom severity earlier in the life course and
dying from HIV infection at higher rates. Early life exposure to stress is linked to key biological processes,
specifically inflammation and shorter leukocyte telomere length, which are associated with HIV-related
comorbidities and age-related diseases. It is well documented that young Black SMM experience multilevel
sexual minority stress, such as sexual identity concealment, victimization, and community homophobia -
products of stigma which further complicate health outcomes. Thus, understanding factors that may attenuate
the effects of inflammation in younger ages is a critical period to mitigate HIV-related disparities later in life.
Cannabis use is a noteworthy modifiable factor for investigation, given the substantial evidence of its role in anti-
inflammatory processes and its rapidly accelerating legal and social acceptance; however, the rigor of prior
research examining the influence of cannabis on inflammation and other key biological processes is limited
because studies have mostly been cross-sectional, used self-reported measures of cannabis use, and are not
generalizable to young Black SMM with HIV. To address these gaps, this K23 proposal – Cannabis Use and
Proximal Immune Dysregulation (CUPID) – will fortify my Career Development efforts to (1) understand how
biomarkers of cannabis may influence inflammation and leukocyte telomere length and (2) examine the
modifying role of multilevel sexual minority stress. This K23 proposal will chart a pathway to achieve my long-
term Career Goals of becoming an R01-funded investigator with expertise in multilevel determinants of
biobehavioral processes underpinning HIV-related health disparities to guide the development of interventions
with Black SMM with HIV. To accomplish my career goals, I will need training (1) to develop a comprehensive
understanding of biomarkers of cannabis use, inflammation, and leukocyte telomere length; (2) to advance my
understanding of multilevel sexual minority stress assessment in Black SMM; and (3) to develop expertise in
analyzing longitudinal data. An accomplished, interdisciplinary Mentorship Team committed to supporting my
transition to an independent investigator will provide guidance on the training and research activities. Specific
Aims are (1) to determine the relationship between cannabis use and biomarkers of inflammation and leukocyte
telomere length; and (2) to evaluate whether individual- interpersonal- community- and societal level sexual
minority stress moderate the relationship of cannabis with inflammation and leukocyte telomere length. CUPID
will inform the development of an R01 proposal for a more definitive cohort study to further elucidate the bio-
behavioral pathways whereby cannabis use, and sexual minority stress are linked to inflammation and leukocyte
telomere length in Black SMM with HIV.

Public health relevance
PROJECT NARRATIVE Limiting exposure to adverse social conditions and circumstances, and susceptibility to the biological embeddings of social determinants of health across generations is among NINR’s highest priorities. Given that young Black SMM ages 16-35 years with HIV have the highest rates of morbidity, identifying potentially modifiable pathways earlier in the life course (i.e., adolescent and emerging adulthood) could close the gap on health disparities in this population. The K23 proposal, Cannabis Use and Proximal Immune Dysregulation (CUPID), aims to determine the therapeutic potential of cannabis use and its influence on the immune system and leukocyte telomere length in Black SMM with HIV in the presence of multilevel sexual minority stress.